High Performance PET/CT Scanner

Project Summary/Abstract
This application seeks support from the ORIP High-End Instrumentation Grant program to
purchase a high-performance PET/CT scanner to be used for basic/translational/clinical research
at the MGH/HST Athinoula A. Martinos Center for Biomedical Imaging. The proposed instrument
– Siemens Biograph Vision Quadra – has a 1-meter long axial field of view and uses the latest
generation PET detectors with excellent time-of-flight performance. The one order of magnitude
higher sensitivity of the Biograph Vision Quadra PET/CT would benefit existing and future projects
by allowing investigators to: obtain higher quality PET images, reduce radiation exposure and/or
imaging acquisition time, image longer time after radiotracer administration, perform simultaneous
multi-organ dynamic acquisition, improve the PET data quantification, perform multi-tracer
studies, increase the temporal resolution of the PET measurements, etc. These new opportunities
will benefit the ongoing research projects of our multidisciplinary NIH-funded investigators from
MGH and Greater Boston region. Furthermore, the substantially better PET performance
combined with the high-performance CT will complement the capabilities of the conventional
PET/MRI and MRI scanners installed at the Martinos Center and will foster opportunities for new
projects and collaborations for projects ranging from cardiovascular and pulmonary diseases to
oncological and non-oncological whole-body applications. The proposed purchase through this
SIG is being supported by the MGH leadership, Radiology Department, and Martinos Center. This
multi-level institutional support covers every aspect related to the upgrade and its future
operations, including allocation of instrument space and assistance for installation, operational
support in terms of system scheduling, accounting, and maintenance, and lastly but most
significantly, a commitment of up to $7,500,000 to cover the gap between the NIH SIG award and
the purchasing price for the upgrade, in addition to the committed fund of $150,000 from the MGH
Executive Committee for Research towards the maintenance of the system. Following the
installation, the Biograph Vision Quadra PET/CT will be managed by the Martinos Center as a
shared core, and made available to the broader research community, both within MGH and the
Greater Boston region.

Public health relevance
Project Narrative This application seeks support to install an extended axial field of view PET/CT tomograph at the MGH/HST Athinoula A. Martinos Center for Biomedical Imaging. The new instrument will offer dramatically enhanced performance compared to state-of-the-art PET/CT instruments that will benefit the research projects of our multidisciplinary users from MGH and Greater Boston region, and will foster opportunities for new projects and collaborations.